ECHO Renewal for the INSPIRE Study Cohort

ABSTRACT
The overarching goals of this proposal are 1) to maintain retention of children in the INSPIRE birth
cohort with emphasis on diversity, and implementation of the ECHO Cohort Protocol with high fidelity, and 2)
tackle the major limitation in diagnosis and management of childhood asthma - addressing the need to identify
asthma phenotypes and endotypes to develop targeted treatment and prevention strategies.
The term asthma is an umbrella diagnosis for several disease states with distinct variable clinical
presentations (phenotypes) and mechanistic pathways (endotypes). Central to understanding the causal role of
environmental exposures in asthma development and to disease management is identifying distinct asthma
phenotypes. The scientific aims of this proposal are: 1) Aim 1: to determine the incidence and prevalence
of two highly relevant asthma phenotypes, atopic and non-atopic asthma, by age, sex, cohort decade and
geographic location, using widely available and harmonized variables and those collected through the ECHO
Cohort Protocol. We will also determine the contribution of established environmental risk and protective
factors with these specific clinically relevant asthma phenotypes. Lastly, we will calculate comparative
estimates of childhood asthma morbidity by asthma phenotypes; 2) Aim 2: to further characterize asthma
phenotypes and endotypes into clinically useful entities within the ECHO consortium and expand the findings
to clinical practice by utilizing available or to be collected samples to add biomarkers of asthma routinely
available in clinical practice, and nasal samples to perform transcriptomic analyses to define asthma
endotypes; 3) Aim 3: to facilitate and oversee longitudinal follow-up of the established INSPIRE cohort, and
biosample collection to maximize retention of existing participants with emphasis on diversity, and implement
the ECHO Cohort Protocol with high fidelity. The INSPIRE birth cohort is a population-based birth cohort study
that originally enrolled over 1950 term healthy infants. INSPIRE is unique in including surveillance for infant
respiratory viral infection through biweekly active and passive surveillance using PCR for viral detection and
respiratory syncytial virus (RSV) serology at age one. The children will be ages 8-10 years when the current
ECHO funding period ends, entering adolescence, and will be followed to age 15-17 years during this next
funding period.
The proposed research is an innovative, novel, multi-faceted and practical approach to move away
from viewing “asthma” as a single umbrella disease, and identifying and understanding asthma phenotypes,
endotypes, and the influence of risk and protective factors on specific asthma phenotypes. The approach we
propose is also practical in moving toward solutions that utilize currently available technologies and laboratory
testing to aide in development of diagnostic criteria for childhood asthma sub-types.

Public health relevance
NARRATIVE The term asthma is an umbrella diagnosis for several disease states with distinct variable clinical presentations (phenotypes) and mechanistic pathways (endotypes). In clinical care for childhood asthma, treatments are largely applied universally to all children with asthma, even though it has been shown that some treatments we use may not benefit certain asthma sub-types. The focus of this proposal is to define clinical asthma sub-types so that they may be easily identified in clinical practice, understand their distinct disease biology, and determine what risk factors promote asthma sub-type development with the goal to have targeted treatment and prevention strategies.